Characterization of Altered Immunity in Patients with Inflammatory Arthritis Induced by Immune Checkpoint Inhibitor Therapy

PROJECT SUMMARY/ABSTRACT
This proposal describes a rigorous training program for the career development of Dr. Sang Kim as an
independent physician-scientist.
The principal investigator is a physician-scientist who completed his PhD in immunobiology and his clinical
rheumatology fellowship at Yale University. His career goal is to become an independent investigator studying
rheumatic complications induced by immune-based cancer therapeutics. He proposes to expand his training in
T cell and cancer immunology through an intensive training research experience under the mentorship of Dr.
Roza Nurieva, a world leader with unparalleled intellectual and technical insight into the role of T cells in cancers
and autoimmune diseases. In addition, because interactions of tumors and the host immune system are critical
in development of immune-related adverse events (irAEs) induced by cancer immunotherapy, and because
cutting-edge genomic technologies are a powerful tool in understanding the complex biology of the immune
system, Dr. Kim will also have an opportunity to study cancer/functional genomics under the mentorship of Dr.
Andrew Futreal (co-primary mentor), a world-renowned scientist in cancer genomics.
The research objective of this proposal is to investigate mechanisms of arthritis associated with immune
checkpoint inhibitor therapy (arthritis-irAE). Preliminary data for this proposal revealed the predominance of Th1
cell signatures in the patients with arthritis-irAE. In addition, Th17 cells were expanded in arthritis associated
with combined PD-1 and CTLA-4 inhibitor therapy with steroid resistance. Furthermore, Dr. Kim observed that
more CD4+ T cells were polarized into Th17 cells in skewing conditions in the presence of combined PD-1 and
CTLA-4 inhibitors than in the presence of PD-1 inhibitor alone. From these results, Dr. Kim hypothesizes that
Th1 cells play a critical role in the pathogenesis of arthritis-irAE and that Th17 cells are pivotal in steroid-resistant
arthritis-irAE induced by combined PD-1 and CTLA-4 inhibitors. To address the hypothesis, Dr. Kim will
investigate mechanisms leading to development of arthritis-irAE, with special focus on Th1/Tc1, Th17/Tc17, and
regulatory T cells, and determine mechanism-driven biomarkers to predict development of arthritis-irAE, reflect
arthritis disease activity, and predict steroid resistance.
This proposal serves as a training vehicle for Dr. Sang Kim to become an expert in rheumatic complications
induced by immune-based cancer therapy, an explosively emerging and challenging clinical entity in
rheumatology.

Public health relevance
PROJECT NARRATIVE Despite unprecedented clinical success in the treatment of advanced cancers, immune checkpoint inhibitors are associated with immune-related adverse events. Understanding the mechanisms of immune-related adverse events is critical to identify valid biomarkers to predict and assess these events and to establish the optimal treatment strategy targeting autoimmunity while preserving antitumor immunity, both of which are triggered by immune checkpoint inhibitors. This work seeks to determine the cellular and molecular mechanisms underlying arthritis associated with immune checkpoint inhibitor therapy by utilizing patient samples.